CLINICAL TRIAL OF HIGH BLOOD PRESSURE CONTROL--YOUNG URBAN AFRICAN AMERICAN MALES

In 1996, the Studies of Ocular Complications of AIDS HPMPC Peripheral Cytomegalovirus Retinitis Trial (HPCRT) was completed. It showed that cidofovir (HPMPC) given as an induction at 5mg/kg IV once weekly for two weeks, followed by maintenance at either 5mg/kg once every two weeks or 3 mg/kg once every two weeks was effective in controlling CMV retinitis. For patients assigned to deferral, the median time-to- progression of the retinitis was 21 days, whereas for those assigned to low-dose cidofovir it was 69 days and to high-dose cidofovir, the median was not reached. The current method of treatment administration using the co-administration of Probenecid and intravenous hydration as well as intermittent dosing minimized but did not completely eliminate nephrotoxicity.